Cellular origins and molecular mechanisms of arthrofibrosis

ABSTRACT
Arthrofibrosis is a debilitating fibrotic joint disorder, which causes excessive scar tissue formation within the joint
and surrounding soft tissues after injury and/or surgery leading to painful restriction of joint flexion and extension
that persists despite rehabilitation. Damage to the joint resulting in chronic inflammation activates proliferation
and differentiation of progenitor cells, also known as
fibro-adipogenic progenitors, into highly specialized pro-
fibrotic cells that deposit excessive amounts of disorganized collagen causing contraction. Estimated rates of
arthrofibrosis induced by knee surgery, such as anterior cruciate ligament
reconstruction or total knee
arthroplasty, affects a significant number of suffering patients with prevalence ranging from 12%-35%.
Unfortunately, there is a significant gap in knowledge of the molecular and cellular biology and pathophysiology
of arthrofibrosis, which limits mechanism-based therapies. Thus, to date, there is no available non-surgical, non-
invasive treatments to prevent or cure arthrofibrosis and management only includes treating the symptoms and
not the underlying cause. Pathogenesis of organ fibrosis is mediated by the aberrant activity of pro-inflammatory,
pro-fibrotic cytokines, including IL-6 family that signal through gp130 transmembrane protein. Alas, specific
cellular and molecular mechanisms that trigger fibrotic processes and responses downstream of gp130 remain
elusive. Our previously published data demonstrates that manipulation of gp130 signaling upstream prevents
fibrosis development after joint injury rats in vivo. In our recent study, we have identified a signaling residue
within gp130 receptor that is responsible for triggering inflammatory and fibrotic responses in the joint and other
tissues in vitro and in vivo. The study also suggests that fibrotic outcomes are induced by a gp130-mediated
arginine metabolism and hence, the current grant application is designed to investigate the significance of this
circuit in arthrofibrosis. To illuminate on this mechanism in depth, we will employ several new genetic mouse
lines to ablate central players in arginase metabolism including Arg2, Odc1 genes in fibrogenic cells in a murine
model of arthrofibrosis. First, we will investigate whether polyamine production by ARG2/ODC1 enzymes, which
catalyze abnormal ECM synthesis upon tissue injury, can promote knee arthrofibrosis after post-traumatic joint
injury in vivo. In parallel, we will employ our generated CRISPR/Cas9 mutant mouse with a point mutation in
gp130 intracellular domain to test whether local delivery of polyamines to the knee will lead to arthrofibrosis in
the injured mice. Furthermore, we will assess the contribution of different progenitor populations to arthrofibrosis
in mice, and lastly, will elucidate whether the mechanism of gp130-induced fibrosis is conserved in human
fibroprogenitors. The experiments in this proposal are designed to define the role of the arginine metabolism
downstream of gp130 and determine whether genetic modulation of this mechanism can prevent or halt fibrosis
progression in vivo after injury.

Public health relevance
PUBLIC HEALTH RELEVANCE Arthrofibrosis is a fibrotic disorder that occurs specifically in the joint that is initiated by an inflammatory reaction to injury or surgery and often causes significant pain and disability. The ultimate objective of the proposed project is to investigate and validate a novel biological module as a potential therapeutic target for arthrofibrosis via analysis and genetic modulation of the gp130-related arginine metabolism axis in fibrosis-initiating progenitor cells. These data are essential for advancing new small molecule-based therapeutic approaches for preventing and/or restoring joint function after trauma or major surgeries, which in turn will reduce the morbidity and use of addictive pain medications.